Investigation of the Mechanism(s) of Beta and Delta Cell Coordination Under High Glucose

Pancreatic islet crosstalk is essential to maintain blood glucose homeostasis. Central to this crosstalk are the
somatostatin (Sst)-secreting delta cells, which serve to regulate the activity of insulin-secreting beta and
glucagon-secreting alpha cells. Crosstalk between beta and delta cells is of particular importance as it is often
lost or dysregulated in diseases characterized by dysglycemia like diabetes and congenital hyperinsulinism
(CHI). It is well established that insulin and Sst secretion are coordinated, but there is no consensus on the
mechanism of this coordination. Published data demonstrating a 30 second lag between insulin and Sst secretion
coupled with our previously published observation that the beta cell hormone Urocortin 3 stimulates delta cell
Sst secretion illustrate the importance of paracrine coordination of beta-delta cell secretion. However, an
alternative and potentially parallel mechanism is gap junction coupling. Preliminary data using the calcium
reporter GCaMP6s simultaneously expressed in beta and delta cells demonstrates that delta cell response to
high glucose is profoundly heterogenous compared to beta cells, with both beta cell coordinated and
uncoordinated calcium oscillations observed in the majority of delta cells. Based on these data delta cells can
be subdivided into 7 distinct subpopulations suggesting that a single mechanism may be insufficient to fully
describe beta-delta cell coordination. This has informed the hypothesis that delta cells coordinate with beta cells
predominantly via paracrine signaling with a minor subpopulation of highly synchronous delta cells showing
calcium behaviors consistent with gap junction coupling. The mechanism(s) of crosstalk between beta and delta
cells will be addressed in two aims. Aim 1 will focus on how gap junction coupling could contribute to coordinating
a small subpopulation of highly synchronous delta cells. Aim 2 will focus on the role paracrine signaling plays in
coordinating the majority of delta cells with beta cells during glucose stimulation. To assess the extent of gap
junction coupling in Aim 1 the whole cell patch clamp technique will be used to deliver small gap junction
permeable tracers into beta and delta cells within intact islets. To investigate the role of gap junction coupling
between beta cells and this small subset of highly synchronous delta cells live cell Ca2+ imaging will be followed
by post-hoc immunohistochemical staining of Cx36. To address the predominant role of paracrine signaling in
coordinated delta and beta cell activity in Aim 2, inhibitors of secretion will be used while assessing changes in
the level of coordination between beta and delta cells via Ca2+ imaging. These approaches are innovative by: 1)
connecting heterogeneous delta cell behavior to underlying mechanisms of coordination in response to glucose
stimulation in intact islets. 2) resolving the predominant mechanism(s) of coordination between beta and delta
cells. These aims are significant as they will definitively establish the mechanism(s) by which beta and delta cells
communicate to coordinate their activity in response to high glucose, paving the way for the development of
novel therapeutics aimed at re-establishing healthy islet crosstalk in diseases like diabetes and CHI.

Public health relevance
The proposed research is relevant to public health because there is currently no clear consensus of the mechanism by which beta and delta cells coordinate their Ca2+ and hormone secretion in response to elevated blood glucose. The proposed mechanisms complement existing observations and link delta cells with distinct patterns of Ca2+ behaviors to specific mechanisms of coordination. The proposed research is relevant to NIDDK’s mission because it directly addresses the mechanism of beta-delta cell coordination, which is a crucial aspect of islet crosstalk to regulate insulin secretion that can be leveraged to improve the quality of life for millions of Americans afflicted with diseases of impaired glucose homeostasis.